Novel Pharmacological Probes Targeting Exchange Proteins Activated by cAMP (EPAC)

Enter the text here that is the new abstract information for your application. This section must be no longer than 30 lines of text.

Public health relevance
PUBLIC HEALTH RELEVANCE: Our study focuses on developing novel chemical probes specifically targeting an important signaling protein that has been implicated in many human diseases including pancreatic cancer. These new chemical probes can be used in studying disease mechanisms and in developing medications.